BIOLOGICAL MARKERS IN CSF IN SUBJECTS WITH AMYOTROPHIC LATERAL SCLEROSIS

The purpose of the study is to measure potential biological markers in cerebrospinal fluid of patients with amyotrophic lateral sclerosis (ALS).